Penn+Plus Clinical Research Center

PROJECT SUMMARY/ABSTRACT
The University of Pennsylvania Prevention of Lower Urinary Tract Systems Clinical Center
(PENN+PLUS CC) is a diverse, experienced, committed and invaluable member of the
Prevention of Lower Urinary Tract Symptoms (PLUS) Network, presenting an exceptional team
of interdisciplinary investigators bringing expertise in adolescent and women’s pelvic health
care, health behavior and prevention science, instrument development, and epidemiology. We
are distinguished by our focus on implementation science and our unique location at the
intersection of urban and rural areas and benefit from the significant and unique wealth of
resources of UPenn. In Phase 1, the PENN+PLUS investigators made significant contributions
to all PLUS publications and presentations during Phase 1. This includes 11 articles published
or in press, 6 submitted manuscripts, and 26 refereed national and international presentations
For Phase 2, to bolster the strength of our engagement with the community, we have partnered
with the Penn Community Engagement Core, which will develop a realistic plan for inclusion of
community partners, and have added new team members as Co-investigators, Drs Heather
Klusaritz and Terri Lipman, who have expertise in community-based participatory research
methods. We propose specific aims for Phase 2 efforts that address all of the needs stipulated
in the RFA, including support for a nationally representative population-based large cohort study
of bladder health (Aim 1), a project to develop and validate a novel tool for evaluating bladder
self-care among adolescent girls and women (Aim 2), and pilot testing of a community-based
bladder health promotion program (Aim 3).

Public health relevance
PROJECT NARRATIVE PENN+PLUS CRC (PENN+PLUS), an exceptional team of interdisciplinary investigators, has made significant progress over the past 5 years, producing 11 articles published or in press, 6 submitted manuscripts, and 26 refereed national and international presentations.